Confirmatory Efficacy of the Building a Strong Identity and Coping Skills Program for Low-Income Young Adolescents

PROJECT SUMMARY
Levels of adolescent anxiety, depression, and suicidality have been steadily rising over the last decade
and have reached record levels in the wake of the COVID pandemic, prompting declarations of a national
emergency in youth mental health. These alarming trends are especially dramatic for youth living in poverty,
and low-income youth who are members of minoritized racial or ethnic groups and those living in isolated rural
areas, who experienced some of the most severe impacts from the pandemic. The COVID pandemic and its
mitigation efforts exacerbated these disparities by increasing potent stressors such as social isolation, loss,
and family disruptions. Mental health risks evident for diverse low-income adolescents are further compounded
by limited access to culturally affirming services made even scarcer in the pandemic. Waitlists at many youth-
serving clinics approach 12 months, and access to affordable services is even more limited. Equally important
is the dearth of interventions designed specifically to meet the needs of low-income adolescents that are
trauma-informed, and based on inclusive empowerment principles, contextual strength-based frameworks, and
firm empirical evidence. The Building a Strong Identity and Coping Skills (BaSICS) program is a trauma-
informed coping and empowerment intervention for early adolescents exposed to chronic stress that (1)
teaches individual and collaborative skills for coping with stress and trauma, (2) develops positive social
identity, and (3) culminates in group-based community action. By building supportive relationships with peers,
improving active engagement coping, fostering identity development, and empowering youth to action, BaSICS
gives adolescents tools with which to address the myriad stressors to which they are exposed.
The proposed work aims to replicate and extend the findings from a smaller-scale trial of BaSICS
where, relative to control group, youth randomized to BaSICS acquired targeted coping and self-regulation
skills and demonstrated improved cortisol reactivity and reduced internalizing problems. The proposed study
will examine treatment effects on depression, anxiety and suicidality in clinically referred youth from four sites
across central Pennsylvania. The proposed project will also extend prior findings by integrating data across
multiple biological stress response systems to further evaluate the potential for BaSICS to re-calibrate
dysregulated stress physiology. Enrolling low-income youth from various racial and ethnic groups and from
urban and rural areas, the trial will enable examination of potential moderators of BaSICS that can inform
future dissemination efforts. The proposed study promises to further NIMH’s Strategic Framework on Youth
Mental Health Disparities by improving our understanding of interventions with potential to reduce mental
health disparities. Adding to our mental health arsenal a biologically potent, targeted intervention that
balances the need for fundamental self-regulation and coping skills with the need for a culturally affirmative
strength and resource building approach, could help move the needle on socioeconomic health disparities.

Public health relevance
PROJECT NARRATIVE Socioeconomic disparities in physical and mental health problems are large, persistent, and severe and stem in part from adaptations to biological, cognitive, affective and behavioral systems necessitated by chronically stressful developmental contexts. Interventions attending to these adaptations and taking the context of a child’s development seriously are needed to address the ever-growing health disparities affecting low-income youth. The proposed study promises to further NIMH’s Strategic Framework on Youth Mental Health Disparities by improving our understanding of culturally affirming interventions with potential to treat internalizing syndromes and disorders, protect against biological embedding of chronic stress, and reduce mental health disparities.